The Local Infiltration Therapy (LIT) Trial for Pain Control Following Hip Fracture Fixation

Geriatric hip fractures are an increasingly prominent public health problem with more than 300,000 fracture
sustained within the U.S. each year and predicted over 1,000,000 by 2050. These fractures are life changing
in elderly patients and sustaining a post-operative complication can be severely debilitating. Post-operative
pain can be a significant driver of poor outcome via an increased risk of post-operative complications, including
delirium which is associated with increased mortality, morbidity and outcome which persists beyond index
hospitalization. Pain control is frequently managed with opioids which elderly patients are particularly
susceptible to the negative side-effects they entail, which include somnolence, delirium, nausea, vomiting,
urinary retention and respiratory depression. Additionally, increased opioid use in the context of the current
opioid epidemic is further concerning and elderly patients are just as susceptible as other age groups. Thus,
decreasing opioid use in these patients is paramount in decreasing complications and ultimately improving
outcome for this deserving group of patients. In a pilot, double-blinded, multi-centered placebo-controlled trial
we recently conducted, we reported a decreased use of opioids following hip fracture fixation and decreased
pain visual analog scores (VAS) with the usage of liposomal bupivacaine. In a follow-up retrospective study,
we demonstrated that the use of an injection cocktail of commonly available medications (Clonidine,
Epinephrine, Ropivacaine, Toradol) demonstrated a similar and possibly greater decrease of opioid use and
pain VAS when compared to liposomal bupivacaine. The injection cocktail is associated with less cost than the
commercial liposomal bupivacaine and may be a more cost-effective alternative to liposomal bupivacaine.
Given these findings and large support for both of these modalities in the arthroplasty literature, evaluation of
the approach to improve outcomes in the hip fracture population is crucial to helping prevent complications and
poor outcomes in these patients. This proposal aims to initiate and complete the planning of a multi-center,
double-blind, non-inferiority trial with placebo for effect size determination to test our hypotheses that a
pharmacy prepared cocktail is not inferior to a commercially available liposomal bupivacaine, and that local
injection therapy can improve pain control following hip fracture fixation. We will utilize existing research
relationships between clinical sites to complete the protocol, optimize procedures, prepare a budget, develop
protocol forms, optimize recruitment procedures, develop a standard procedures manual, perform regulatory
submissions and recruit additional sites as necessary to complete the proposed trial. Given the severity of
complications associated with poor pain control, successful planning and completion of this trial can potentially
introduce a method of pain control which is opioid free and widely adaptable with minimal resources.

Public health relevance
Geriatric hip fractures are common and associated with high morbidity and mortality, with more than 300,0000 fractures sustained each year in the U.S. Opioid limiting pain control using local injection therapy following hip fracture fixation may improve outcomes by decreasing complications associated with poor pain control and opioid use in this population. This grant aims to support the planning of a clinical trial which will assess the effectiveness of these novel injections in the treatment of post-operative pain following geriatric hip fracture fixation to improve outcomes in geriatric hip fractures.